Sigma factor networks of M. tuberculosis

DESCRIPTION (provided by applicant): A critical aspect of the bacterial stress response is the reprogramming of RNA polymerase (RNAP) by changing the sigma factor, a subunit that determines promoter specificity. Substituting one sigma factor with another in the RNAP holoenzyme results in the expression of hitherto silent cellular functions. These newly expressed functions lead to the metabolic, morphological, and physiological changes that are required for bacterial adaptation to the new environmental conditions and survival. The ability of the human pathogen Mycobacterium tuberculosis to establish and transmit infection is tightly associated with the extensive gene expression reprogramming that allows this microorganism to switch between replicating (growth) and nonreplicating (dormancy) states during infection. The need for complex gene regulation is reflected in the highest accessory sigma factor/genome size ratio seen in M. tuberculosis among obligate pathogens. The premise of our work is that understanding the stress response of M. tuberculosis requires elucidating the biology of this microorganism's sigma factors. Central to sigma factor biology are the regulatory interactions among sigma factors, which are transcriptional and post-transcriptional. In the present R21 application, we propose to reconstruct the architecture of the sigma factor transcriptional network and to test the network response to stress conditions. The experimental approach is built around three aims, which are characterized by the increasing complexity of the network tested. These are: (1) to identify direct regulatory interactions between M. tuberculosis sigma factors expressed in E. coli, (2) to assess the effect of stress-response independent activation of sigma factor genes on the expression of downstream sigma factor genes in M. tuberculosis, and (3) to characterize the sigma network response following exposure to bacteriostatic stressors. Successful completion of the aims will enable us to identify all the direct and indirect transcriptional interactions between sigma factors and to generate hypotheses toward future reconstruction of a larger, multi-scale regulatory network that will include post-transcriptional control of sigma factor activity and the involvement of additional classes of stress-sensing and regulatory factors. Full knowledge of the sigma factor network is expected to identify sigma factors that are part of the developmental switch between growth and dormancy. These sigma factors (and the regulatory pathways controlling their expression and activity) become potential targets for anti-tuberculosis intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal aims to reconstruct the transcriptional regulatory network of sigma factors, which mediate bacterial adaptation to the environment and response to stress, in the human pathogen M. tuberculosis, the causative agent of tuberculosis. Characterizing this network will help define hypotheses about ways to alter the pathogen's ability to respond to stress and survive in a variety of environments. This proposal aims to reconstruct the transcriptional regulatory network of sigma factors, which mediate bacterial adaptation to the environment and response to stress, in the human pathogen M. tuberculosis, the causative agent of tuberculosis. Characterizing this network will help define hypotheses about ways to alter the pathogen's ability to respond to stress and survive in a variety of environments. __SpecificAimsTextDelimiter__ A. Specific Aims Accessory sigma factors are critical proteins that mediate bacterial adaptation to the environment and response to stress. By changing the sigma factor subunit bacterial cells reprogram RNA polymerase (RNAP) to recognize and transcribe sets of genes expressing cellular functions that are critical for bacterial survival. The number of accessory sigma factor genes in a bacterial genome generally reflects the complexity of the environmental conditions encountered by the bacterium or the complexity of the developmental program that has evolved in response to stress. The human pathogen Mycobacterium tuberculosis exhibits the highest accessory sigma factor/genome size ratio among obligate pathogens, suggesting a need for complex gene regulation in this microorganism's life cycle. Indeed, the tubercle bacillus switches between replicating (growth) and non-replicating (dormancy) states during infection, thereby requiring extensive gene expression reprogramming. Our long-range goal is to unravel regulatory mechanisms of growth state changes of M. tuberculosis that are associated with stress. To achieve our goal, we adopt a network-based approach because it has become increasingly clear that the presence of regulatory feedback loops and redundancies hinder a complete understanding of gene regulation by reductionist studies of particular interactions between individual genes and regulons. Thus, reconstructing the regulatory network architecture is seen as a pre-requisite to the understanding of the network response to a signal(s), which is ultimately responsible for the organism's adaptation and survival. We propose to use the R21 mechanism to reconstruct the initial core of the sigma factor network architecture (that is, the direct and indirect transcriptional regulatory interactions between sigma factors) and to test the network response to stress conditions. When the network response is not explained by the direct and indirect transcriptional interactions between sigma factors identified in the present grant, hypotheses will be generated for future testing of additional regulatory mechanisms. In particular, full reconstruction of the M. tuberculosis sigma factor transcriptional regulatory network will complement the study of sigma factor post-transcriptional control, which is beyond the scope of the present application. Our specific aims are: Aim 1: To identify direct transcriptional regulatory interactions between M. tuberculosis sigma factors expressed in E. coli. E. coli strains will be constructed carrying one plasmid in which each of 13 M. tuberculosis sigma factor genes (one essential and 12 accessory) is expressed under an IPTG- inducible promoter and a second, compatible plasmid carrying the upstream sequences of each of 12 accessory sigma factor genes M. tuberculosis fused to lacZ. b-galactosidase activity will be measured in IPTG-induced cultures. Aim 2: To assess the effect of stress-response-independent activation of sigma factor genes on the expression of downstream sigma factor genes in M. tuberculosis. Strains of M. tuberculosis will be constructed carrying a chromosome-borne, tetracycline-inducible copy of each accessory sigma factor gene. Expression levels of downstream sigma factor(s) will be measured by quantitative PCR (qPCR) in tetracycline-induced, exponentially growing cultures. Aim 3: To characterize the sigma factor network response following exposure to bacteriostatic stressors. Exponentially growing cultures of M. tuberculosis will be exposed to stressors at bacteriostatic concentrations: decreased pH, glucose starvation, nitric oxide, oxidative stress (diamide treatment), and cell-surface stress (SDS treatment). Expression levels of sigma factor genes will be quantified by qPCR in serial samples collected at multiple times post-treatment. qPCR data will be mapped against the networks reconstructed in Aims 1 and 2. Successful completion of the aims will identify direct and indirect transcriptional interactions among sigma factors, recognize regulatory and possibly functional redundancy, point to involvement of other transcription regulators and post-transcriptional control mechanisms in the response to particular stress conditions, and help generate hypotheses concerning the effects of manipulating particular regulatory nodes on the survival of tubercle bacilli under stress conditions in culture and in infected animals.